TBI leads to degeneration of afferent neuronal projections

Traumatic brain injury has many sequelae resulting from the initial injury that exacerbate neural
degeneration and functional deficits, which may emerge over long times following the initial
injury. While many studies have examined secondary neuronal loss in the penumbra of the
injury site that occurs due to the induction of inflammatory cytokines and an altered trophic
environment, the impact of these changes in the injured tissue on afferent axons that project to
the injury site from distal locations has not been investigated. In particular, basal forebrain
cholinergic neurons (BFCN) project throughout the cortex and hippocampus, and these neurons
are critical for numerous cognitive functions. These neurons express all the neurotrophin
receptors, the Trk family (TrkA, TrkB, and TrkC) which promote neuronal survival and axonal
growth, as well as p75NTR, which can promote neuronal death and axon degeneration.
Therefore, the consequence of altered levels of trophic factors in the target regions of these
neurons may critically impact the integrity of their axonal projections and ultimately have
negative consequences for the cognitive functions supported by these neurons. Using the fluid
percussion injury (FPI) model to induce moderate TBI in mice, we will investigate the immediate
and long-term consequences of cortical injury on the afferent basal forebrain neurons. Using
compartment culture strategies, we will investigate mechanisms of axonal signaling that mediate
retrograde degenerative responses. Understanding the full scope of damage that occurs as a
consequence of TBI is critical to developing therapeutic strategies to limit the negative
consequences of the injury.

Public health relevance
Traumatic brain injury causes damage and functional deficits associated with the site of injury, but also can affect afferent neurons that project to the injured regions from distal locations, affecting their ability to function properly and possibly causing them to degenerate. Basal forebrain cholinergic neurons, which project throughout the cortex, play a major role in many cognitive functions and are particularly vulnerable to degeneration in Alzheimer’s disease and other cognitive impairments. To understand the full scope of damage resulting from TBI, and to develop therapeutic approaches to minimize the consequences of the brain injury, we will investigate how damage to the cortex affects afferent neurons that project to the injured target, and whether they undergo degenerative changes as a consequence of the injury.